Mechanisms governing post-transcriptional regulation of neuronal microRNAs

PROJECT SUMMARY
Many aspects of neural plasticity require changes in gene expression, either by altering transcription in the
nucleus or by targeting RNA molecules post-transcriptionally. Post-transcriptional regulation may be
particularly important for allowing neurons to regulate protein production in a rapid and compartment-specific
manner. MicroRNAs (miRNAs) influence post-transcriptional gene expression by targeting mRNA molecules
for translational repression and degradation and are known to influence neural development and function. A
growing body of evidence also suggests that post-transcriptional regulation of miRNAs contributes to
experience-dependent synaptic plasticity. However, much remains unknown about the post-transcriptional
mechanisms that control miRNA expression. One such mechanism is target-directed miRNA degradation
(TDMD), a phenomenon in which trigger RNA molecules direct the degradation of specific miRNA molecules. It
was recently shown that TDMD in mammals is mediated by the ZSWIM8 ubiquitin ligase. Preliminary data
indicate that dozens of miRNAs are ZSWIM8 sensitive in the mammalian brain, including several miRNAs that
have previously been linked to synaptic plasticity, suggesting that the TDMD pathway is poised to have
widespread effects on the nervous system. Mice with altered ZSWIM8 expression also exhibit perturbed
expression of many physiologically relevant mRNAs, including genes encoding ion channels and synaptic
adhesion molecules, further supporting the hypothesis that TDMD affects neural development and physiology.
This proposal will assess how TDMD affects neurobiology by (1) determining how ZSWIM8 influences activity-
dependent gene expression; (2) identifying TDMD trigger RNAs that drive miRNA degradation in mouse and
human neurons; and (3) establishing how TDMD influences neuronal activity and the morphology and plasticity
of dendritic spines. Collectively, this work will expand our understanding of the regulatory pathways controlling
neuronal gene expression and their downstream consequences for neural function.

Public health relevance
PROJECT NARRATIVE Neurons rely on proper control of gene expression to make appropriate connections during development and to mediate experience-dependent plasticity and memory formation. These gene-expression pathways are tuned by microRNAs (miRNAs), short RNA molecules that modulate gene expression by targeting mRNAs for translational repression and degradation. This proposal will address how neuronal miRNAs themselves are governed, thereby opening a new window into the mechanisms underlying neurological disorders that arise due to mis-regulation of neuronal gene expression.